Mechanical coordination and mechano-biochemical feedback in epithelial folding

During embryogenesis, the formation of body plan is largely driven by remodeling of epithelial
tissues. While epithelial morphogenesis is regulated biochemically by genes and molecules, it is also
an intrinsically mechanical process controlled by cellular forces and tissue mechanical properties.
Despite significant progress in deciphering the genetic and biochemical determinants of force
generation, little is known about how tissue mechanical properties are regulated and how this regulation
impact morphogenesis. The proposed study addresses these questions in the context of epithelial
folding, a fundamental tissue construction mechanism in development.
Using Drosophila gastrulation as a model, our recent studies have elucidated how local tissue
mechanical properties and global mechanical coordination are exploited by the embryo to facilitate
mesoderm invagination, and how these apparent “passive” tissue properties are regulated by active
cellular processes and feedback mechanisms. During gastrulation, mesoderm precursor cells constrict
their cell apex and subsequently invaginate from the surface of the embryo by forming a ventral furrow.
We found that as the tissue constricts apically, the tissue interior behaves as a viscous continuum and
forms a laminar flow. This viscous response involves prompt cell surface expansion that relies on the
function of the PI 4-kinase Four Wheel Drive (Fwd). In addition, we found that the transition from apical
constriction to mesoderm invagination relies on compressive forces generated in the surrounding
ectodermal tissues, which facilitate tissue folding by promoting mechanical bistability in the mesoderm.
This long-range mechanical coordination is contingent on effective mechanical coupling between the
mesoderm and the ectoderm. Finally, we found that the embryo employs a feedback mechanism
involving Rab11-mediated vesicle trafficking to reinforce the physical integrity of the supracellular
actomyosin network, allowing the tissue to promptly adapt to a rapid increase in tissue tension.
In the proposed study, we will use a multipronged approach combining genetics, optogenetics,
quantitative live-imaging, cell biology and biophysics to (1) investigate the mechanism underlying
Rab11-medaited feedback regulation of actomyosin during apical constriction, (2) determine how PI-4
kinases and their product, PI4P, regulate force-induced cell surface expansion and how cell surface
“expandability” determines local and global tissue mechanical properties, and (3) determine how tissue
compression is generated in the ectoderm to promote long-range mechanical coordination during
mesoderm invagination. Successful completion of our research goals will advance scientific knowledge
by elucidating the regulatory networks and physical principles that dictate how tissues generate, sense
and respond to mechanical forces to establish proper form and function in development.

Public health relevance
The folding of 2-dimensional epithelial sheets into multilayered tissues provides a key strategy to shape tissues during embryogenesis. We use the model organism the fruit fly Drosophila melanogaster to determine the molecular and mechanical mechanisms of epithelial folding. Our findings will be critical to understanding how epithelial cells integrate various developmental signals to form complex tissue and organ structures and how defects in this process result in embryonic lethality and congenital birth defects.